Elucidation of the mechanisms of jumbophage genome protection during infection

In the face of a public health crisis of pathogenic bacteria resistant to most existing antibiotics, bacteriophages
(bacterial viruses; phages) that naturally infect and kill bacteria, represent a promising alternative for use as
antimicrobials. However, a significant obstacle to realizing this translational goal is presented by the plethora of
immune mechanisms in bacteria to resist phage infections. Overcoming this obstacle necessitates phages
equipped with robust anti-immune capabilities to kill multiple isolates of antibiotic-resistant pathogenic bacteria.
In that regard ΦKZ-like jumbophages (phages with genomes > 200kb) emerge as a family with an outstanding
ability to thwart a multitude of bacterial nucleolytic immune systems throughout infection and numerous family
members that infect most important Gram negative pathogens. The jumbophage ΦKZ is a broad-host range
killer of the multi-antibiotic resistant pathogenic bacteria Pseudomonas aeruginosa and the leading model
phage for the jumbophage family. Immune evasion is achieved largely through the assembly of a
phage-encoded proteinaceous nucleus-like “shell “compartment that encapsulates and shields the replicating
phage genome. However, it is unknown how this phage protects its genome prior to the assembly of the shell.
The long term objective of this proposal is to understand the mechanisms used to guard the ejected genome of
ФKZ-like jumbophages–preliminary evidence (from us and others) suggests the assembly of a macromolecular
compartment in infected cells at similar locations as the ejected jumbophage genome (prior to shell assembly).
Currently, the composition and biological significance of these complexes remain unknown. I hypothesize that
this complex (termed herein the ‘ejected structure’) creates a DNA-containing organelle that encapsulates and
protects the ejected phage genome from immune nucleases. I will first use fluorescence microscopy and
cryo-electron tomography to visualize the infection state prior to shell assembly. From these studies I will gain
high resolution structural insight into the biogenesis and organization of these compartments. In parallel, I will
use mass spectrometry to reveal the constituents of these assemblies and subsequently interrogate the
functional roles of these constituents in supporting phage infection. From my multidisciplinary studies, I stand
to uncover fundamentally new phage biology in addition to innovative and potentially transferable mechanisms
to enhance phage success in the fight against pathogenic bacteria.
I will perform this work at UCSF, an institute that hosts state-of-the-art research facilities and fosters an
intellectually rigorous and collaborative research environment. Co-supervision in the Bondy-Denomy and
Agard labs will ensure thorough training in phage biology, genetics and biophysics. Through the course of my
research, I will undergo extensive training and subsequently gain expertise in diverse fields of microbiology,
molecular biology, biophysics and structural biology that I need to fulfill my postdoctoral training goals and
subsequently pioneer an independent research program.

Public health relevance
PROJECT NARRATIVE Viruses called bacteriophages kill bacteria through fascinating and diverse mechanisms making them timely therapeutic candidates to combat antibiotic resistant pathogens. Here, I study a phage that potently kills Pseudomonas aeruginosa using bizarre and previously unobserved mechanisms to hide from anti-phage immune enzymes like CRISPR-Cas. This multidisciplinary project will unveil the molecular details of this remarkable immune evasion mechanism to guide identification and development of better phage therapeutics.